UNC Neuroscience Center Research Cores: Administrative

PROJECT SUMMARY- ADMINISTRATIVE CORE
The Administrative Core provides management for the Center grant Core services. The Administrative Core will
ensure that the Microscopy Core and the Bioinformatics Core operate smoothly to support projects of Qualifying
Investigators, other investigators in NINDS-priority areas, and young investigators. The Administrative Core also
assesses work flow of the two Cores and monitors the prioritization plan. Finally, the Administrative Core
monitors the activity reports prepared by the Core Directors and oversees the recharge arrangements in place
for each Core.